THERAPY OF CONTINUING LEFT VENTRICLE HYPERTROPHY AND HYPERKINESIA

Can one medically treat the continuing left ventricle hypertrophy, hyperkinesis and increased sympathetic activity which continues years after relief of afterload stress with captopril or a beta blocker? We will test results with plasma renin activity, echoes, a muga and magnetic resonance imaging.